Impact of Age-Related Clonal Hematopoiesis on Alzheimer's Disease

PROJECT SUMMARY / ABSTRACT
The goal of this proposal is to establish whether age-related functional changes in peripheral immune cells
influence Alzheimer's disease (AD) pathology onset and progression. While immune dysfunction is a hallmark
of AD pathogenesis, peripheral-central nervous system crosstalk is not completely understood, creating a barrier
to the development of new therapeutics for prevention or cure. The foundation of proper immune responses is
the hematopoietic system's ability to produce well-functioning cells in correct proportions. Hematopoietic stem
cells (HSCs), which produce all blood cells (including monocytes, neutrophils, T cells, and B cells), accumulate
somatic mutations over their long lifetimes. Certain mutations provide a selective advantage that results in an
increased expansion of those HSC “clones” and can lead to skewed proportions of and phenotypic changes in
produced cell types. The incidence of this phenomenon, termed clonal hematopoiesis (CH), increases with age
and is associated with higher risk of multiple diseases. Surprisingly, CH has been recently reported to be
associated with decreased incidence of AD. To validate this association and propose an actionable mechanism
for clinical disease intervention, we need to understand how mutations in peripheral immune cells impact the
etiology and progression of AD. These studies necessitate mammalian models in which CH and AD
proteinopathy are inducible in the same individual and blood and brain are available for examination prior to
disease onset and throughout disease progression. Our research objective is to investigate the impact of Tet2
CH mutation on the ability of peripheral immune cells to infiltrate the brain and modulate AD pathology. To
achieve our aims, we will introduce mutated cells into the circulation of well-defined AD mouse models. We will
assess the effect of aging and proteinopathy development on the extent CH peripheral cell infiltration, identify
and quantify infiltrating immune cells and their locations within the brain, determine whether circulating CH cells
are increasingly primed for mobilization, and assess the effect of CH on AD pathology development. Determining
that a CH mutation a) increases the immune cell infiltration into the brain, and b) leads to deceased pathology
would provide a direct link between CH and AD and may nominate new candidates for therapeutic intervention
for AD.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease (AD) has a devastating effect on patients, caregivers, and society, and effective therapeutic interventions are urgently needed to prevent and cure dementia. An age-related blood phenomenon called clonal hematopoiesis (CH) was recently identified as a potential protective factor for AD in a population study; however, validation and mechanistic studies are not possible in humans. Our project will model CH and AD in mice to uncover mechanistic links between peripheral blood and brain dysfunction and nominate new resilience and protective targets for AD.